Electronic cigarette use in lung cancer patients

TITLE: Electronic Cigarette Use in Head, Neck, and Lung Cancer Patients
PROJECT SUMMARY/ABSTRACT
The overall goal of this proposal is to facilitate Dr. Theodore Brasky’s development into an established and
independent investigator for tobacco control. For this research, he will focus on cancer patients and the impact
of electronic cigarettes (e-cigs) on cigarette smoking, quitting, and health outcomes. It is established that
cigarette smoking adversely affects the cancer patient in many ways. E-cigs have the potential to reduce
cigarette smoke exposures, related toxicities, and foster smoking cessation. However, almost no research
exists to substantiate this hypothesis. Dr. Brasky is a cancer epidemiologist and member of the Ohio State
University Comprehensive Cancer Center (OSUCCC) with considerable expertise in the analysis and
interpretation of longitudinal data. Due to a strong institutional environment, he has been participating in
various tobacco-focused research projects over the past several years. Excited by this, he wants to take
advantage of the extraordinary opportunities in tobacco control related to e-cigs. The proposed training plan
will enable him to obtain expertise and experience in tobacco research (e.g., coursework in tobacco regulatory
science), intervention studies (e.g., coursework in clinical research methods and translational behavioral
research), and primary data collection in complementary studies. This training will capitalize on the exceptional
institutional environment at OSU and an experienced mentor in tobacco control in Dr. Peter Shields, Deputy
Director of the OSUCCC. Herein, Dr. Brasky will address critical research gaps that will aid in the
understanding for the impact of e-cigs on the cancer patient generally, and specifically for the creation of sound
policy decisions by the Food and Drug Administration. This proposal requests a funded extension to complete
Dr. Brasky’s research goals due to significant COVID-19 related interruptions. The Specific Aims are to: 1)
analyze an observational cohort of 184 head, neck, and lung cancer patients and examine the associations of
e-cigs with smoking reduction, smoking cessation, quality of life, and treatment toxicities; and, 2) Evaluate
feasibility, acceptability, compliance, and safety of a pilot patient-choice trial of a pod-based e-cig versus
standard of care in 40 head, neck, and lung cancer patients planning to undergo surgical resection. These
complementary studies will be among the first to examine associations in patients with tobacco-related cancers
and will share assessment measures. Results from this research will yield critical data in order to provide
sound and evidence-based decisions on e-cigs.

Public health relevance
PROJECT NARRATIVE Electronic cigarettes are increasingly used in cancer patients and despite marketing that suggests a health benefit, almost no data exist to corroborate such claims. This K07 will provide strong career development training in tobacco control, intervention study design and analysis, and primary data collection through didactic coursework and hands-on experiences. This training will support the implementation, analysis, and interpretation of the proposed research aims of examining in head, neck, and lung cancer patients the associations of electronic cigarette use with combustible cigarette smoking reduction and cessation, as well as for quality of life and treatment toxicities, using complementary study designs and shared assessment measures.